Identifying acoustic-level and language-specific sensory processing mechanisms

Speech perception is modulated by experiences with native language phonotactic patterns. Sensory
processing of speech is fundamental to perception, language learning, and language comprehension however
much is unknown about how neural signals become language-specific within the cortical information stream.
Preliminary evidence suggests that language experience with phonotactic patterns modulates acoustic-level
sensory processing at early cortical stages (<150 ms) through feedback within the low frequency bands of the
electroencephalogram (EEG). However, there are conflicting reports on the timing of the modulatory effects,
and few, if any, cross-linguistic investigations of native and non-native phonotactic patterns that examine the
direction of information flow within cortical networks. For this project, we will analyze 96 EEG datasets,
previously obtained from 24 native Polish and 24 native English-speaking adults as they listened to same and
different spoken nonword pairs during two listening conditions, an Attend and Passive condition. Nonwords
within the pairs contained the onset sequences /pt/, /pət/, /st/, and /sət/ that occur in the Polish and English
languages, except for /pt/, which never occurs in English in the word onset position. Analysis of this dataset will
test the hypothesis that language-specific sensory processing occurs early within the cortical information
stream (<150 ms) through information flow directed to phonological processing regions in auditory cortex.
Multiple methods of analysis including AEPs, measures of time-frequency from brain source-level channels,
current source density, and measures of brain connectivity, including coherence and Granger causality-based
connectivity will be used to carry out the specific aims. Aim 1 will determine whether sensory processing of
spoken nonwords is language-specific within the context of selective attention at early cortical stages. Aim 2
will evaluate whether sensory processing of spoken nonwords is language-specific within the context of
repeated phonological sequences at early cortical stages. Aim 3 will determine the spatial distribution of
language-specific activity and the direction of information flow during sensory processing of native and non-
native phonotactic patterns and within the contexts of attention and repetition suppression. The outcomes will
clarify sensory processing mechanisms of speech perception.

Public health relevance
Speech perception, how one hears speech sound sequences and associated stress patterns, is specific for native speakers of a language. Understanding how the brain transforms physical signals of speech to be specific for native language speakers is critical because this process is fundamental to language comprehension and has translational significance for individuals with phonological processing impairments.